INTRAMUSCULAR &INTRAVENOUS ADMINISTRATION OF HUMAN MENOPAUSAL GONADOTROPINS (HUM

To compare the intramuscular administration of Pergonal to intravenous pulsatile infusion. Measurement of serum levels of gonadotropins, estradiol, and follicular development will be made.